Role of Cdk9 in the Pathogenesis of Pulmonary Fibrosis

Project Summary/Abstract:
The long-term objectives of this proposal are to reveal new and novel druggable targets and/or elements of
fibrogenic pathways, thereby yielding new insights into better treatment strategies for idiopathic pulmonary fibrosis
(IPF). IPF is one of the most frequent interstitial lung diseases and has a poor prognosis with worse outcomes than many
malignant cancers. The two FDA-approved therapeutic agents (nintedanib and pirfenidone) have entered clinical use
recently. Of most concern, while these drugs may slow the decline in lung function to a certain extent, both drugs fail
to effectively halt lung fibrosis and improve patient survival. Therefore, there is an urgent need for new and improved
therapeutics.
In order to achieve higher clinical efficacy, current therapeutic approaches seek drugs that have dual activities
against inflammation and fibrosis. To achieve dual activities effectively, we identified a novel central regulator, cyclin-
dependent kinase 9 (Cdk9), that controls a common checkpoint for transcriptional activation of genes involved in major
inflammatory and fibrotic signaling pathways. Preliminary data show that Cdk9 is elevated in IPF fibroblasts, which
drives the aggressive nature of these cells. Treatment with Cdk9 inhibitor reduced the aggressiveness of the cells, and in
mouse models of IPF, Cdk9 inhibitor increased survival and reduced fibrosis. These data support the hypothesis that
Cdk9 inhibitors can be effective therapeutics to halt or reverse the progression of pulmonary fibrosis. This proposal
aims to investigate the mechanistic roles of Cdk9 in IPF and validate Cdk9 as a new anti-inflammatory and anti-fibrotic
pharmacotherapeutic target for treating IPF.
The approach is to firmly establish a central role of Cdk9 in governing both inflammatory and fibrogenic
processes. Our scientific premise rests upon the principle that a potent therapeutic approach to counteract inflammation
and fibrosis concurrently can be attained by targeting Cdk9. Three specific aims are proposed, SA1) use gain-and-loss
of function analyses to elucidate the molecular mechanism by which Cdk9 regulates IPF pathogenesis and progression,
and screen a panel of clinical stage Cdk9 inhibitors for their effectiveness against fibrosis; SA2) test the therapeutic
potential of the top performing Cdk9 inhibitor in a bleomycin-induced lung injury mouse model; and SA3) establish
therapeutic proof-of-concept by developing an inhalable formulation of Cdk9 inhibitor and demonstrating efficacy in
the bleomycin mouse model. Our vision is to generate pre-clinical mechanism-of-action data to support future
development of a Cdk9 inhibitor-based IPF therapeutics.

Public health relevance
Project Narrative: Pulmonary fibrosis is the scarring of lung tissues and there are no therapeutic treatments to halt or cure this deadly disease. This research will reveal new and critical knowledge of disease mechanism and identify new and novel druggable targets for effective treatments that could improve and prolong the quality-of-life of patients.